HEALing Communities Study Data Coordinating Center

Project Summary/Abstract
The United States continues to grapple with an opioid overdose crisis that exacts a heavy, and increasing,
toll on morbidity and mortality. Evidence-based practices (EBPs) developed to address this ongoing crisis
include opioid overdose education and naloxone distribution programs; prescription drug monitoring programs
and guidelines for opioid prescribing; FDA-approved medications for opioid use disorder; treatment initiation
and retention interventions; and recovery support services. However, these EBPs do not sufficiently penetrate
community settings where opioid misuse and opioid use disorder are prevalent, nor are they utilized by local
stakeholders, including people who live, work, and use drugs in communities.
The HEALing Communities Study (HCS) designed the Communities That HEAL (CTH) intervention, a
community-engaged, data-driven planning process to rapidly achieve reductions in opioid overdose deaths in
67 communities across four U.S. states: Kentucky, Massachusetts, New York, and Ohio. The CTH intervention
includes three components: (1) community engagement; (2) the Opioid-overdose Reduction Continuum of
Care Approach (ORCCA); and (3) a set of communication campaigns to reduce stigma and drive demand for
EBPs.
As the Data Coordination Center (DCC), RTI will translate and disseminate intervention products that are
customized to specific audience information needs, health literacy levels, and preferences for communication.
Our experienced team, engaged with the HCS parent study, will employ end user–focused methods to drive
dissemination efforts under this supplement through two specific aims. We will accelerate translation of HCS
research to practice by adapting the Community‐Engaged Research Dissemination framework (Aim 1), and we
will engage HCS stakeholders and external experts to create dissemination products based on the community
engagement components of the CTH intervention and the ORCCA (Aim 2).
The DCC has experience overcoming the challenges associated with developing and executing a cohesive
dissemination strategy that elevates the scientific and public visibility of a research collaborative. We are led by
multiple Principal Investigators—Drs. Emmanuel Oga, LaShawn Glasgow, and Gary Zarkin—who are
experienced leaders of multisite studies and experts in substance abuse, program management, and
consensus building. The broader team of Core Leaders brings robust scientific and implementation science
skills interwoven with a deep understanding of prevention science of opioid misuse and addiction. Targeted
and rapid dissemination of community engagement lessons from the CTH intervention will provide practice-
based guidance to communities on how to respond to their local opioid crisis.

Public health relevance
Project Narrative The HEALing Communities Study (HCS) developed and implemented a community-engaged intervention, the Communities that HEAL (CTH), as a model to rapidly achieve reductions in opioid overdose deaths. Results of this ongoing intervention will not be fully realized until data collection and analyses are completed. This supplement aims to leverage the HCS infrastructure to accelerate the dissemination of selected CTH intervention materials, specifically community engagement guidance and the Opioid Overdose Reduction Continuum of Care Approach (ORCCA) menu of best practices and implementation resources, to provide practice-based guidance to communities on how to respond to their local opioid crisis.